HIV Drug Resistance Monitoring in Chennai, India

DESCRIPTION (provided by applicant): Infection due to HIV-1 Subtype C accounts for more than 50% of the global epidemic and nearly all HIV infections in India. Drug resistance is the major cause and consequence of antiretroviral treatment failure. Genotypic resistance assays estimate drug susceptibility and provide guidance to clinicians and policy makers. Though recommended by HIV treatment guidelines in the West, genotyping is rarely performed in public health clinical care in India and other resource limited settings, mainly due to cost and access constraints. This proposal will allow examination of whole blood for transmitted and acquired HIV drug resistance at YRG-CARE in Chennai, India; development of an Indian subtype-C specific point mutation assay that targets the most common drug resistance mutations that occur upon failure of antiretroviral therapy; and validation of the point mutation assay results by Single Genome Sequencing. The Specific Aims are to (1) define prevalence of drug resistance in plasma RNA and proviral DNA in treatment naive and experienced HIV-1 subtype C infected patients at YRG- CARE in Chennai, India. We will test the hypotheses that the detection of drug resistance mutations in proviral DNA predicts transmitted resistance among treatment naive subjects, and virological failure among subjects on treatment; and (2) investigate whether point mutation assays are sensitive and specific in the detection of key drug resistance mutations in plasma RNA and proviral DNA, compared to genotypic gold standards. We will explore the lower limit of detection of minority drug resistance mutations compared to population genotyping and validate quantification of drug resistance mutations by a point mutation assay comparing it to single genome sequencing. These Specific Aims will expand knowledge of the development of HIV drug resistance in India, and allow comparison of HIV RNA and DNA drug resistance mutations by consensus sequencing and by an innovative point mutation assay. This India and US research collaboration will promote technology transfer that has the potential to impact HIV drug resistance surveillance and HIV patient care in India.

Public health relevance
PUBLIC HEALTH RELEVANCE: Optimal monitoring of antiretroviral therapy in HIV-infected patients includes laboratory tests to evaluate the virus in blood plasma, such as virus load testing to determine the amount of virus, and viral genotyping to identify drug resistance. These are expensive tests which require a cold chain and sophisticated laboratory facilities, usually not available or affordable in public health treatment in India and other resource limited settings. In such circumstances detection of critical archived drug resistance mutations in cellular proviral DNA could be an efficient and lower cost way to measure transmitted resistance, and assess HIV drug resistance among patients receiving treatment. In this study we will develop, validate and evaluate the effectiveness of a lower cost laboratory method to identify drug resistance in proviral DNA. __SpecificAimsTextDelimiter__ Monitoring Resistance in Chennai Kantor, Rami; Katzenstein, David A. Specific Aims Millions of HIV-1 subtype-C infected individuals, in India and Southern Africa, initiate first-line antiretroviral therapy (ART) using inexpensive nucleoside and non-nucleoside reverse transcriptase inhibitors (NRTI; NNRTI). HIV drug resistance (DR) is the major global cause of ART failure. Emerging DR also poses a challenge to effective pre and post-exposure prophylaxis. DR may be transmitted to partners, leading to first- line treatment failure. Most studies determine prevalence and patterns of first line ART DR in plasma viral RNA. Few studies examine archived DR mutations (DRM) in proviral DNA among those receiving first or second-line regimens. Comparison of RNA and DNA DR in subtype C and rapid detection of DR using subtype specific point mutation assays (PMA) may enhance treatment monitoring, drug switching and adherence counseling to sustain suppression and prevent DR transmission. These assays can be developed as low cost, locally produced tests to detect key DRM, with immediate impact on improving treatment outcomes and reducing emergence of DR in resource-limited settings (RLS). Using our existing strong US-India collaboration, the Specific Aims of this proposal are to: 1. Define prevalence of DRM in plasma RNA and proviral DNA in ART naïve and experienced HIV-1 subtype C infected patients in a public health treatment program at YRG-CARE in Chennai, India. Plasma and peripheral blood mononuclear cell (PBMC) samples will be assayed for DRMs prevalence in viral RNA and proviral DNA, respectively. We will examine transmitted and acquired DR by dideoxy- sequencing (DDS) among (1) 50 drug naïve patients initiating treatment; (2) 100 first-line ART recipients who are virologically suppressed; and (3) 100 first-line ART recipients who are failing therapy. We hypothesize that the detection of DRMs in proviral DNA will predict DR in drug naïve and virologically failing subjects, and that those with suppressed viral load (VL) will not demonstrate DNA DR. 2. Determine the sensitivity, specificity and lower limit of detection of PMA for DRMs in subtype C virus compared to population genotyping, and validate and quantify minority DRMs using single genome sequencing (SGS). The aim is to assess the prevalence of specific key NRTI and NNRTI DRMs in amplicons from proviral DNA, by using a point mutation assay (PMA) compared to the consensus DDS RNA and DNA genotyping described in Specific Aim 1. A PMA, allele specific polymerase chain reaction (ASPCR), adapted for Indian subtype C, will be investigated. Minority DRMs detected by PMA will be validated with sensitive SGS. We hypothesize that there will be high concordance between PMA detection of the targeted mutations and their presence in population sequences. Performance of sensitive assays to identify minority variants will enhance monitoring and evaluation of DR in ART programs in India and other RLS. These Specific Aims will allow us to examine transmitted (in patients who are ART naïve) and acquired (in patients who are failing ART) DR in HIV-1 subtype C in southern India. It will also allow the development of Indian subtype-C specific methods to monitor DR in India using newly developed methods in diverse analytes. The results will allow us to compare plasma DR patterns to resistance mutations that are archived in cellular DNA; evaluate genotoyping form proviral integrated DNA as a stable alternative analyte for DR monitoring; assess PMA performance in detecting DR in DNA; and compare DR patterns among subtype C viruses from Chennai to other subtype C treatment sites and non-C subtypes. This research will generate data that will be useful for cost-effectiveness analysis of DNA PMA as a DR monitoring tool to be considered in India and other RLS. The ongoing NIH-funded studies as well as the long term and successful collaboration between the PIs' and the Indian co-Investigators, and between their institutions and YRG-CARE, will ensure successful completion of this proposal. The India and US research will promote the continuation of new technology transfer to India, with the potential to incorporate it and impact HIV DR surveillance, monitoring and evaluation with the ultimate goal of improving patient care.